Artificial Intelligence Tool to Optimize Organ Transplantation Outcomes (Transplant-AI)

ABSTRACT
The organ transplantation process faces significant challenges, resulting in poor patient
outcomes, wasted resources, and a growing demand that outpaces the supply. With nearly
120,000 patients on the waitlist and 17 patients dying daily awaiting a donor organ, current
organ matching methods are suboptimal and inadequate. Despite the wealth of data available,
no comprehensive clinical tools exist to aid transplant centers and Organ Procurement
Organizations (OPOs) in making critical, time-sensitive organ allocation decisions.
InformAI is developing TransplantAI, an innovative clinical decision support platform that utilizes
granular, data-driven insights to assist clinicians in making informed decisions regarding organ
use and allocation. This NIH SBIR Fast-Track Phase I/II proposal leverages over 500 relevant
data points, including donor-recipient organ size-matching information, to significantly improve
organ allocation and utilization, ultimately saving lives and lowering healthcare costs.
Phase I builds upon our previous research (2021-2023) in liver and kidney transplantation,
expanding our focus to heart and lung transplantation. As of December 2022, 3,300 patients
were awaiting a heart transplant and 1,000 patients were awaiting a lung transplant. We will
assess the accuracy of machine learning (ML) methods, such as XGBoost, in predicting pre-
and post-transplant outcomes for heart and lung transplant patients, and develop deep learning
U-Net models for accurate organ segmentation from CT scans.
Phase II integrates our previous research and AI models in kidney and liver transplantation with
our Phase I results and AI models in heart and lung transplantation into a human-in-the-loop AI
system for predicting transplant patient outcomes across all organ types (heart, lung, liver, and
kidney). TransplantAI overcomes the constraints of current methods by using advanced
machine learning techniques for more precise risk assessments with explainable factors
impacting predictions and offers a comprehensive method for accurate organ size matching and
improved post-transplant outcomes.
Our SBIR project aims to deliver quantitative and validated outcome predictions at the point of
care for transplant physicians and clinical care teams to improve solid organ transplantation
outcomes. This project addresses critical challenges in organ allocation efficiency and patient
outcomes, paving the way for future advancements in solid organ transplantation.

Public health relevance
PROJECT NARRATIVE The organ transplantation process has many inefficiencies and significant issues that result in less than optimal patient outcomes and impacts to valuable clinical resources. Our product, TransplantAI, aims to transform the organ matching process. By utilizing advanced AI algorithms, large proprietary datasets and access to world renowned medical experts at leading transplant centers and organ procurement organizations (OPOs), the InformAI team plans to address limitations of current transplant analytic models by enhancing data insights into organ discard, waitlist mortality and post transplant survival.